Muscular Dystrophy Specialized Research Center

Project 1 Project Summary
Dystroglycanopathies are a group of congenital/limb-girdle muscular dystrophies that lead to progressive
skeletal muscle weakness and a decline in respiratory function. Defects in the post-translational processing of
the extracellular matrix (ECM) receptor, α-dystroglycan (α-DG), cause dystroglycanopathies. ECM proteins that
contain laminin-G-like (LG) domains bind to α-DG via a unique heteropolysaccharide [-GlcA-β1,3-Xyl-α1,3-]n
called matriglycan. Genetic studies show that mutations in many genes encoding enzymes required for the
post-translational processing of α-DG result in the absence of matriglycan or a reduction in its length and
impair α-DG receptor function. Although respiratory complications negatively affect patients with
dystroglycanopathies, the causes of these conditions are understudied, and we have very little understanding
of the mechanisms that regulate matriglycan synthesis in respiratory muscles or the mechanisms underlying
the respiratory pathophysiology when matriglycan is absent or reduced in size. The overall objective of the
proposed research is to elucidate the cellular and molecular mechanisms that underly respiratory
complications in the dystroglycanopathies. The overarching hypothesis of our research is that a) regulation of
matriglycan synthesis in respiratory muscles requires tissue-specific expression of dystroglycanopathy genes
and enzyme-substrate complexes and b) defects in this process underly the respiratory pathophysiology
observed in patients with dystroglycanopathies. Specific Aim 1 will define the biochemical regulation of
matriglycan synthesis, the laminin-binding properties of matriglycan, and α-DG receptor function in respiratory
muscles using dystroglycanopathy mouse models. Specific Aim 2 will determine the relationship between
matriglycan length and α-DG receptor function and the resulting respiratory pathophysiology in various mouse
models of dystroglycanopathy described in Specific Aim 1. These studies will use plethysmography to measure
respiratory function (ventilation, tidal volume, respiratory rate, number of apneas, and response to hypercapnia
and hypoxia) in order to determine the length and laminin-binding properties of matriglycan that are required to
maintain normal respiratory function and the respiratory abnormalities in the absence or reduction of
matriglycan. Specific Aim 3 will determine the ability of potential therapies in clinical trials to restore full-length
matriglycan and normal respiratory function. These studies will determine the efficacy of current therapies in
clinical trials (AAV FKRP and ribitol supplementation) to restore full-length matriglycan, α-DG receptor function,
and normal respiratory function in dystroglycanopathy mouse models. Collectively, the expected outcome of
these aims is a greater understanding of the pathological mechanisms underlying respiratory complications in
the dystroglycanopathies. Moreover, this knowledge is critical for developing a scientific foundation for the
design and validation of quantitative assays to determine target engagement as well as the development and
improvement of therapeutic strategies to treat respiratory dysfunction in individuals with dystroglycanopathies.